Mechanisms of Assembly and Functional Regulation in Non-canonical Biomolecular Condensates

Project Summary
Biomolecular condensates are micrometer-scale membraneless structures that self-assemble in living cells.
They are ubiquitous across diverse organisms and exist in protein-only conglomerates or protein associated with
nucleic acids. Biomolecular condensate formation is critical to normal cellular processes and the mis-regulation
of condensate assembly or disassembly drives various pathologies. We recently discovered that the pathological
fusion protein EML4-ALK spontaneously forms micrometer-scale condensates in the cytoplasm while lacking
conventional condensate-forming domains or sequence motifs. This condensate elicits a novel mode of cell
signaling by acting as a physical platform that enriches signaling proteins. The recruitment of client proteins to
elevate local protein concentrations implies a general strategy through which multi-protein condensates achieve
biological function. A major gap in the field is that very little is known about condensate-promoting motifs beyond
a few conventional motifs, or about how proteins work together in condensates to achieve their biological function.
We propose a research program that systematically elucidates novel motifs and biophysical principles in protein-
only condensates. This will be accomplished by leveraging innovative approaches such as CRISPR imaging,
optogenetics manipulation, and custom-written analysis and quantification algorithms to pursue two interrelated
research themes. The first theme is identification of alternative mechanisms that enable protein condensate
formation by: discovering novel condensate-promoting motifs by interrogating fusion proteins known or
suspected to form condensates; determining the essentiality and modularity of such motifs; and mapping motif-
function relationships in condensate-mediated processes. The second theme is to uncover physical principles
that regulate composition and dynamics in multi-protein condensates. Although the molecular details may differ,
the sequence space and principles demonstrated here are broadly applicable to a diverse range of proteins and
cellular processes. The long-term objective of our research program is to build an expanded biophysical
foundation to understand biomolecular condensate assembly and functions across cellular homeostasis and
pathology. Such knowledge brings new opportunities to modulate cellular processes through independent
physical approaches instead of traditional ways of interfering with biochemical reactions, and provide a
biophysical framework to prevent, diagnose, and treat condensate-driven diseases.

Public health relevance
Project Narrative Proteins-only biomolecular condensates are a crucial part of normal cellular processes and their mis-regulation is at the heart of various pathologies. Unfortunately, current understanding on what sequence motifs promote the assembly of such condensates and the biophysical principles that regulate their composition and dynamics has been limited. Discoveries from this work will provide a framework in fundamental understanding of these condensates and bring new opportunities to prevent, diagnose, and treat condensate-driven diseases.